Immunogenetic risk factors for exacerbations in African American people with COPD

Project summary/abstract
Individuals with frequent exacerbations of COPD (ECOPD) experience increased risk for mortality and
accelerated lung function decline. We have shown that reduced total IgG, IgG subclasses, and pneumococcal
antibody levels and function are associated with increased ECOPD risk. However, the roles of underlying
genetic variants in IgG and its receptor are not well-known. Our preliminary studies have shown that a distinct
set of IgG are associated with exacerbations among African American participants in a large COPD cohort
study. Our study will investigate the hypothesis that variants in the IgG heavy chain (IGHG) and Fc receptor for
IgG (FCGR) interact to enhance susceptibility to functional antibody deficiencies and ECOPD in African
American patients. Specific Aim 1 will investigate interaction between G3m6 variant of IgG3 and low-
functioning FcγRIIIb alleles as a risk factor for severe ECOPD in African American participants in the
SPIROMICS and COPDGene cohorts. To investigate the hypothesis that G3m6 allotype, in the presence of the
‘NA2’ FCGR3B variant predict increased risk for severe ECOPD, we will first use novel genomic analyses to
determine haplotypes (combinations of alleles inherited from a single parent) for these variants. We will then
confirm these variants using conventional qPCR-based methods. Associations with ECOPD will be analyzed
using longitudinal follow-up data available in both cohorts. Specific Aim 2 will evaluate IgG3 hinge length as a
mechanism for discordance between antibody levels and function, investigating the hypothesis that short hinge
length will be associated with impaired antibody function with preserved antibody levels. We will first measure
antibody levels and function in African American participants in SPIROMICS. We will then compare IgG3 hinge
region length between participants with impaired vs intact antibody function in the presence of normal antibody
levels. This investigation will be used to facilitate further studies of immunogenetic variation as a risk factor for
antibody deficiencies and exacerbations in COPD, and will represent the most detailed study of these variants
in African American cohorts to date. This study will also serve to address a knowledge gap regarding
characterization of IGHG and FCGR variants in people of non-European ancestry. Ultimately these studies will
contribute to our overall goal of developing personalized diagnostic and therapeutic approaches to mitigate the
detrimental effects of frequent ECOPD.

Public health relevance
Project narrative Individuals with COPD who experience frequent respiratory infections have impaired immune responses to bacteria. African American people may have distinct antibody variants that could predispose to respiratory infections, however these variants have not been well-studied in people of non-European descent. We will investigate variants in antibody-related genes in African American people with COPD to facilitate diagnostic and therapeutic approaches for prevention and treatment of exacerbations.